Tracking the life cycle of cells in senescence.

Cellular senescence is a biological program where cells permanently cease to divide in response to
molecular damage, activating the senescence-associated secretory phenotype (SASP). SASP recruits
the immune system to clear these cells. Senescence plays a crucial role in processes like development,
wound healing, and cancer resistance, but its accumulation with age can be detrimental, contributing
to systemic inflammation. Recent single-cell technology studies have revealed significant heterogeneity
in the senescent phenotype. Most research has focused on the variation in cell types and different forms
of senescence induction. However, a less explored aspect is the age of a senescent cell, considering
both the cell’s age at the onset of senescence and the duration it remains in this state. Our previous
work and preliminary results indicate that the senescence phenotype evolves from early to deeper
states, with significant changes in the transcriptome, particularly the SASP, and the epigenome. This
project aims to study how the senescence phenotype changes between young and old cells and as a
function of time in senescence (Aim 1). Additionally, we will advance recent technology based on a
multi-symbol molecular recorder to track the duration of cells in the senescent state (Aim 2). Ultimately,
our project will lay the foundation for studying the age of senescent cells in vivo.

Public health relevance
A significant gap in the field of cellular senescence is our lack of knowledge regarding how long individual senescent cells persist in tissues. This project aims to address this gap by developing methodologies to track the age of senescent cells. We plan to achieve this by identifying markers associated with the age of senescent cells and encoding their state in their DNA using the recently developed DNA typewriter technology.